Utilizing Smart Speaker Technology to Deliver Parenting Education Support to Parents of Young Children

PROJECT SUMMARY/ABSTRACT
Children with externalizing behaviors and self-regulation difficulties as early as preschool are at elevated risk
for socioemotional, behavioral, and academic problems throughout childhood, and for later psychosocial
problems including substance abuse in adolescence. Behavioral sleep/wake problems play an important role in
children’s long-term adjustment as well. Chaotic bedtime and morning periods frequently create conflict and
stress in families, and children’s poor sleep quality and dysregulation at bedtime and in the morning have
negative impacts on their school readiness, executive function, and psychosocial adjustment. In contrast,
predictable, positive family routines improve children’s long-term trajectory for psychosocial and academic
adjustment, especially in at-risk family environments. Evidence-based parenting programs have shown much
value in addressing these problems, but the reach of parenting programs is limited by significant challenges in
engaging and retaining parents. Technology-based parenting interventions have significant potential for
bringing evidence-based parenting supports to parents, but the field lacks programs that bring these supports
to parents on an in-situ basis, such that parents can receive experiential support in fostering healthy routines
for their children. This proposed Phase II study will harness innovative smart speaker technology to complete
development of a tool for parents, “Talk Parenting” (TP), that provides families with engaging, motivating in-situ
support in building healthy family routines. Talk Parenting is an application, or “skill”, for the Amazon “Alexa”
Echo smart speaker devices. In Phase I, a guided Bedtime Routine prototype was created and its feasibility,
acceptability, usability, and initial efficacy established. Phase II will complete development of the TP program,
by enhancing the prototype Bedtime Routine and creating a new Morning Routine and a Calming Down Mini-
Routine. The Bedtime and Morning Routines will guide parents in creating positive bedtime and morning
routines to foster healthy sleep/wake habits and provide experiential practice in self-regulation skills and a
framework for positive parent-child interactions. The Calming Down Mini-Routine will supplement the Bedtime
and Morning Routines, providing support for children’s and parent’s self-regulation during challenging
moments. Families will access this in-situ support through hands-free simple voice commands and interactions
with the smart speaker device. In a rigorous randomized controlled trial, Phase II will evaluate the acceptability
and efficacy of the full TP program for improving parenting practices, parents’ self-efficacy, and stress,
children’s behavioral and sleep/wake problems, and the parent-child relationship, against a usual-care waitlist
control. A sample of 184 families of 3-5-year old children will be recruited through Head Start and other family
support agencies. A stakeholder Advisory Board will also provide feedback on commercial feasibility.
Establishing efficacy and acceptability of the innovative Talk Parenting program will have important
implications for harnessing smart speaker technology to assist parents in-situ with key parenting challenges.

Public health relevance
PROJECT NARRATIVE This project will complete development and rigorously evaluate the acceptability and efficacy of a smart speaker-based application for providing in-situ parenting support to families of 3- to 5-year-old children. The custom-designed smart speaker application, “Talk Parenting”, offers in-situ experiential parenting supports for building positive family bedtime, morning, and “calming down” routines that promote children’s positive health behaviors, self-regulation, cooperation, and a healthy sleep/wake cycle, thus contributing to school success and a positive parent-child relationship, and reducing children’s risk for long-term behavioral and psychosocial problems. Establishing efficacy and acceptability of this innovative parenting tool with families in economically and socially disadvantaged environments will have important implications for harnessing smart speaker technologies to assist parents in-situ with parenting challenges, and further build our capacity to harness technology to improve child and family outcomes.